EFFECTS OF 17-BETA-ESTRADIOL ON RESPONSE TO AMPHETAMINE

This study is designed to investigate interactions between 17-beta- estradiol and subjective, behavioral, and physiological responses to d-amphetamine in normal, healthy women.